ROLE OF NO IN ANTIBIOTIC ACTIVITY OF METRANIDAZOLE

Spin trapping and carbon sensors are used to study the possible role of NO in the antibiotic activity of metranidazole against trichimonas vaginalis. This is an ongoing multi-year project.